IGF::OT::IGF ISELECT INFINIUM CUSTOM SNP ARRAY, 700,000 BEADTYPES FOR NEI (SEDDON) FY 2017 CAN 8469334

The Center for Inherited Disease Research's mission is to support the genetics community by providing high quality, cutting-edge genomic services and technologies in order to expand our understanding of disease and catalyze discoveries that translate to patient care. CIDR is a valuable national resource for cutting-edge genetic research. CIDR was established at the Johns Hopkins University in 1996. CIDR provides high quality next generation sequencing and genotyping services to investigators working to discover genes that contribute to disease. On-site statistical geneticists provide valuable insight into analysis issues as they relate to study design, data production and quality control. Completed studies encompass over 200 phenotypes across 900 projects and over 1.2 million samples from over 300 different principal investigators located world-wide. The impact is evidenced by over 1,190 peer-review publications. In response to the expanding field of genetics, CIDR rapidly implements new technologies and offers new production scale services while maintaining strict quality standards.